DIABETES PREVENTION TRIAL--TYPE 1 DIABETES (ORAL)

The purpose of this study is to see if it is possible to delay or prevent the development of Type 1 insulin dependent diabetes mellitus in relatives of persons with IDDM.